REGULATION OF EXPRESSION OF ANGIOTENSIN CONVERTING ENZYME IN RENAL GLOMERULI

It has been suggested on an experimental basis that elevated intraglomerular pressure leads to glomerulosclerosis. The regulation of angiotensin converting enzyme (ACE) production plays a central role in maintaining normal intraglomerular pressure. This project was designed to isolate the gene encoding ACE from mouse kidney to further study the regulation and expression of the enzyme.